Administrative Core A

The Administration Core is responsible the overall direction and coordination of the research projects, evaluation of research progress, and for the overall and day-to-day administration of the Program. The core director will monitor progress via regular research meetings of program directors and research personnel. The core will also coordinate and schedule journal clubs, research meetings, seminar program, and research retreats. The core is directed by Dr. Michael Ostap, who is director of the PMI. Dr. Ostap has administrative resources provided by the University of Pennsylvania to help support the mission of the core. Specific Aims are (1) to oversee and coordinate the project mission, monitor progress, and establish timelines, and (2) develop, coordinate, and schedule research meetings, journal clubs, symposia, retreats, and visiting scientists programs that are critical to our research mission.